Dynamics of Endomembrane Docking and Fusion

Abstract Summary
COPII mediated ER-to-golgi membrane traffic was first reconstituted using crude cell extracts thirty years
ago. Twenty years ago, the formation of COPII vesicles was recapitulated using pure proteins and lipids.
However, the consumption of COPII vesicles – their uncoating, tethering, docking, and fusion with accep-
tor compartments, is still poorly understood. This is in large measure because the crude transport assay
developed thirty years ago has not been supplanted by a system employing chemically defined components.
In this Project we introduce such a system and use it to test hypotheses about the sequence of biochemical
subreactions in COPII vesicle traffic, the components that execute these subreactions, and the mechanisms
through which they function.

Public health relevance
Public Health Narrative The COPII vesicle pathway, the focus of this grant, is essential for normal cellular function. It is essential for secretion of hormones and antibodies, and is subverted for the assembly of viruses including HIV. Le- sions in genes encoding components of this pathway cause a variety of human diseases. The fundamental research in this Project may ultimately help to guide development of therapeutics to treat viral infections and genetic lesions that cause COPII-associated diseases.